Integration of the thalamic and cortical inputs in the auditory striatum

The overarching goal of this supplement proposal is to support a new graduate student
from underrepresented population, to determine the dysfunctions of the auditory striatum in
aging mice and Alzheimer’s disease (AD) mouse lines.
Difficulty in learning new tasks and making judgements based on sensory information
such as auditory cues are common symptoms in AD patients as well as in normal aging. Previous
studies including my own works indicated that the auditory striatum plays an essential role in
auditory decision-making and learning through its connections with auditory thalamus and
cortex. In this proposal, we will target the research gap by determining the dysfunction of
auditory striatal activity and circuits in aging mice and AD mouse lines, using the approaches and
strategies established in the parent grant.
First the auditory decision-making and learning deficits in the aging and AD mice will be
examined using the auditory frequency discrimination task (cloud-of-tones task) (Aim 1,
behavioral assessment), and then tetrode recordings will be used to determine the changes of
striatal sound representations in the aging and AD mice (Aim 2, physiological assessment, related
to the Aim 1 of the parent grant), finally combination of optogenetic manipulations with
electrophysiological recordings will be used to examine the thalamostriatal and corticostriatal
synaptic activities in the aging and AD mice (Aim 3, circuit mechanism assessment, related to
Aims 1 & 2 of the parent grant).

Public health relevance
Difficulty in learning new tasks and making judgements based on sensory information are common symptoms in aging people and Alzheimer’s disease (AD) patients. Previous studies including my own works indicated that the auditory striatum plays an essential role in auditory decision-making and learning through its connections with auditory thalamus and cortex. In this study we aim to determine the changes of auditory striatal activities in aging mice and AD mouse lines, using the approaches established for the parent grant.